Cellarcus Innovation Corps at NIH

Project Summary Cellarcus Technologies seeks to participate in the Innovation Corps at NIH Program (i-Corps) to better understand the customers and markets for its extracellular vesicle (EV) analysis technology funded under Phase I SBIR R43 DA 044616.

Public health relevance
Project Narrative Cellarcus Technologies is developing innovative new technologies for the measurements of extracellular vesicles (EVs). Cellarcus seeks to participate in the Innovation Corps at NIH Program (i-Corps) to better understand the customers and markets for its EV analysis technology.